Core B: Molecular Biology Core

Project Summary/Abstract
In the past few years, methods to determine the molecular identity neurons that have been labeled by the location
of their projection outputs, the location of neurons providing specific synaptic input, or their ability to respond to
a specific stimulus. Taking advantage of these approaches involves access to highly specialized equipment as
well as the acquisition and application of expertise across myriad unrelated disciplines, including, but not limited
to: microfluidics, low-volume pipetting, macromolecular crowding, bioanalyzer analysis, sequencing chemistry,
large data set management, coding, generalized linear models, graph-based clustering, non-negative matrix
factorization, multiple hypothesis testing correction, etc. Outside of the Molecular Biology Core, none of this
program project grant laboratories has generated or analyzed NGS data, has significant experience with modern
cloning approaches such as isothermal (Gibson) or Type IIS (Golden Gate) Assembly, or designed and used
RNAScope probes. As each group is unlikely to perform such experiments with a frequency that would justify
the time and expense necessary to develop those skills, centralization of these specialized techniques, increases
consistency and quality and reduces cost/time waste resulting from duplicative/inefficient skills acquisition. In
recruiting Dr. Linus Tsai to fill the role of director, the Molecular Biology Core leverages existing capabilities
within his lab, consolidating support services for mouse husbandry and what are more expensive and/or
technically challenging methods (RNAScope, cloning, bulk and single nucleus RNA-seq) to experienced
laboratory and bioinformatic personnel. The Core’s experience with these methods maximizes the likelihood that
these complex and difficult experiments are successful, and in turn that the aims outlined are achieved. In
enabling PPG access to these state-of-the-art methods, we hope to provide PPG members with a basic
understanding of how and when to use these techniques while demonstrate how molecular profiling can quickly
facilitate the identification of pharmacotherapies that would be predicted to increase ventilatory response to
hypercarbia.